Epigenetic DNA modifications regulating neuronal development and synaptic integration

PROJECT ABSTRACT – Project 2 N/A per PAR-14-183

Public health relevance
PROJECT NARRATIVE – Project 2 N/A per PAR-14-183